Decoding microbial-Aryl Hydrocarbon Receptor interactions at the skin barrier interface

PROJECT SUMMARY
An effective epidermal permeability barrier (EPB) protects the skin from dehydration, inflammation, premature
aging, environmental exposure, and infection. Epidermal barrier dysfunction is an important feature of atopic
dermatitis, as well as numerous skin diseases including psoriasis, acne, and rosacea. A fundamental and
holistic understanding of mechanisms regulating homeostatic barrier function is essential to effectively prevent
and manage barrier abnormalities. The EPB function resides in the skin epidermis, which is home to diverse
microbial communities. The microbiome is recognized as a functional unit of the skin barrier. The skin
ecosystem is continuously challenged by the external exposome that includes ultraviolet radiation (UVR), air
pollutants and allergens. Critical for the barrier defense and homeostasis are xenobiotic sensors that recognize
external signals and help identify beneficial (e.g., commensal microbes) from harmful (e.g., pollutants,
pathogens) xenobiotics to regulate barrier defenses. Recently, I have demonstrated that commensal microbes
regulate epidermal differentiation and barrier permeability of the skin by activating xenobiotic sensor, the aryl
hydrocarbon receptor (AHR). However, the mechanisms by which commensal microbes regulate EPB through
AHR under homeostasis, and in presence of environmental insults such as UVR are unexplored. The central
hypothesis of this proposal is that tuning of epithelial responses by modulating AHR-commensal interactions
can alter barrier permeability. This project utilizes ‘multi-omics’ approaches by integrating transcriptomics,
metagenomics, and metabolomics to understand host-microbiota interactions in skin barrier repair. In Aim 1, I
will identify microbial signals from a synthetic commensal community that can activate AHR. These studies will
lead to identification of microbial ligands that can be used to target AHR in barrier diseases. In Aim 2, I will test
contributions of commensal microbiome in protecting against UV-induced barrier damage and use multiomics
approaches to characterize microbiome-host-UV interactome in the context of AHR signaling. These studies
will provide a framework to generate therapies that leverage understanding of environmental-host-microbiome
interactions. During the K99 phase, I will be trained in metabolomics to identify microbial metabolites. I will
receive advanced training in bioinformatics and systems biology approaches that focus on integrating multiple
omics datasets. The outstanding training environment at the University of Pennsylvania coupled with the
excellent advisory committee I have assembled, will greatly facilitate my research during the mentored phase
as well as launch my career with the skills necessary for understanding the role of the microbiome-host-
environment interactome in regulating skin barrier repair.

Public health relevance
PROJECT NARRATIVE A fundamental understanding of mechanisms regulating skin barrier function is essential to effectively prevent and manage skin conditions associated with epidermal barrier dysfunction such as, atopic dermatitis, psoriasis, and photoaging. Skin microbiome can improve barrier function and is an untapped resource for developing microbiota-based therapies that can prevent skin diseases. The proposed studies will deepen understanding of skin barrier regulation and lead to identification of microbiota-based therapeutics for preventing skin barrier dysfunction.